Development and evolution of self-organizing pigmentation patterns

Project Summary
The emergence of complex tissue patterns from seemingly uniform, undifferentiated cells during
development is an essential feature of all multicellular organisms. One of the most prominent theoretical
mechanisms often invoked to explain biological pattern formation is the reaction-diffusion (RD) model, which
postulates that local activation of pattern differentiation factors combined with long-range inhibition of the
activity of those factors can produce dynamic, self-organizing spatial patterns. Numerous empirical and
simulation studies have suggested that the RD mechanism underlies a wide range of pattern formation
processes. However, we still know very little about the actual genes encoding the hypothetical activation
and inhibition factors in most empirical systems, even less about the biophysical properties of these factors
where candidate genes have been identified, and virtually nothing about how modulation of the properties of
these activators and inhibitors affects pattern evolution in nature. The overall objective of this project is to
address these fundamental questions by elucidating the detailed genetic and developmental mechanisms of
pigment pattern formation and evolution in the wildflower genus Mimulus (monkeyflowers), a system
amenable to rigorous genetic analysis, developmental interrogation, and phenotypic perturbation. The work
proposed here will build on our prior efforts that identiﬁed a pair of MYB proteins underlying the formation of
dispersed anthocyanin pigment spots in Mimulus flowers. This MYB pair forms a local autocatalytic
feedback loop and a long-range inhibitory feedback loop, fulfilling the tenets of a classical activator-inhibitor
RD model. Our goals in the coming years are to: (i) experimentally determine the biophysical properties of
the activator-inhibitor pair, including their diffusion coefficients, degradation (clearance) rates, and relative
activation and inhibition constants; (ii) characterize the genetic and developmental bases of pattern
evolution from dispersed spots to longitudinal stripes between closely related species; and (iii) identify the
key cis-regulatory elements that constitute the activator-inhibitor interacting network and test the function of
this two-component, activator-inhibitor module in other tissue types and heterologous systems. Towards
these ends we will use a suite of approaches, including fluorescence imaging, genetic mapping, transgenic
manipulation, and mathematical modeling. Together our efforts will provide an in-depth view of how the RD
mechanism generates self-organizing spatial patterns and modulates pattern evolution in a real biological
system, lending empirical support to the mathematically elegant but somewhat controversial RD model.

Public health relevance
Project Narrative The self-organizing, reaction-diffusion mechanism underlies the developmental process of a wide range of vertebrate traits, including embryonic axis specification, lung branching, palatal rugae formation, hair follicle spacing, and digit patterning, all directly relevant to human health. This project aims to elucidate the molecular details of a two-component reaction-diffusion system that controls the formation and evolution of self-organizing pigmentation patterns. Findings from this project will provide important insights towards understanding how the reaction-diffusion mechanism generates self-organizing spatial patterns during the development of multicellular organisms in general.